Inhibitory Control of Prefrontal Cortex

ABSTRACT Anxiety is a construct in Research Domain Criteria (RDoC) of NIMH’s Strategic Plan and a debilitating symptom of most psychiatric disorders including PTSD, major depression, schizophrenia, autism and addiction. Treatment of anxiety is mostly limited to benzodiazepines, which have abuse potential and produce multiple cognitive and behavioral side effects, including increased propensity to develop dementia. Design of alternative treatments or prevention strategies is contingent upon a better understanding of the neuronal basis of anxiety. While animal studies have so far informed us about the functional neuroanatomy of fear and anxiety, the negative impact of real-life anxiety extends beyond aversive feelings and involves disruptions in ongoing goal-directed behaviors. For example, anxiety is associated with deficits in flexible cognitive control of behavior, and disruptions in expression of motivated behavior when it is subject to the risk of an aversive outcome. The neural basis of these behavioral deficits is largely unknown. Thus, the overarching research question that drives the experimental aims of this application is: How do neurons compute goal-directed behaviors under anxiety? To address this question, a major challenge of the experimental approach is to create a background state of anxiety that does not prohibit animals to perform goal-oriented tasks during electrophysiological recordings from multiple regions. With this in mind, we propose to use two complementary experimental models of anxiety in combination with innovative and clinically relevant behavioral tasks while measuring dynamic coordination between neurons of two regions implicated in anxiety: dorsomedial prefrontal cortex (dmPFC) and ventral tegmental area (VTA). Specific aims are designed based on a computational-style model to test two specific hypotheses: (1) Behavioral differences (between control and anxiety states) are specific to conditions that involve action selection under conflict or the risk of an aversive outcome. (2) Differences (between control and anxiety states) in neuronal activity are observed during conflict/aversive outcomes and involve diminished recruitment of action encoding neurons in dmPFC and disrupted coordination between dmPFC neural activity and VTA dopamine neurons. This approach is novel and significant because a neurocomputational understanding of aberrant neural activity relevant to symptoms such as anxiety can help identify biological markers and clinical measures that delineate etiology and pathophysiology of those symptoms.

Public health relevance
PROJECT NARRATIVE Anxiety is a debilitating symptom of most psychiatric disorders including PTSD, major depression, and addiction. The proposed studies aim at understanding the neurocomputational basis of anxiety and its impact on goal-directed behavior.